Dynamic immune cell landscape in late-onset Alzheimer's disease: role of ApoE-mediated microglial lipid metabolism

Project Summary
Alzheimer's disease (AD) is the leading cause of dementia in older adults and affects over 5 million individuals
in the United States alone. The more common form of AD, late-onset, is a multifactorial disorder in which ApoE4
is the most potent genetic risk. The ApoE4 isoform is also linked to midlife obesity which can cause cognitive
decline in older adults. Obesity is a condition of chronic inflammation characterized by activated immune cells
and increased inflammatory mediators in the blood. Recently, through genetic association studies, microglia and
other myeloid origin immune cells have emerged as crucial players in AD pathogenesis. Single-cell RNA
sequencing analysis in mouse and human AD brains has identified a distinct subset associated with amyloid
plaques and the upregulation of ApoE in microglia. Therefore, further investigation of microglia and other immune
cells is needed to understand how these cells are affected by ApoE4 isoform and obesity contributing to late-
onset AD progression. Our objective in this R21 project is to explore the gene-environment interactions between
ApoE4 and obesity in regulating phenotypic plasticity of microglia and peripheral immune cells. This project aims
to identify molecular pathways that could restore healthy immune function to treat late-onset AD. Our Specific
Aims are to (1) Assess dynamic changes of brain immune cell populations influenced by ApoE4 and diet-induced
obesity in human ApoE isoform knock-in mice; (2) Identify altered lipid metabolism in ApoE4 microglia that
modulates the phenotypic plasticity. The successful completion of this project will reveal the multifaceted roles
of ApoE4 in modulating immunometabolism. Moreover, it will provide a strong rationale for lifestyle interventions
or individualized therapeutic strategies for late-onset AD in ApoE4 carriers.

Public health relevance
Project Narrative Alzheimer’s disease (AD) and obesity are significant health problems and expected to increase dramatically in the next decade. By focusing on how genetic factors, like ApoE4 and environmental risk factors like dietary fat might contribute to late-onset AD in older adults, we can prevent or reduce the cognitive deficits.